Role of Adaptive Myelination in Auditory Brain Plasticity

Project summary/Abstract
Continuous auditory input is crucial for maintaining neural circuitry in the auditory brain. During aging, reduced
auditory input can reorganize central auditory circuits and impair auditory processing. Hearing loss and central
auditory dysfunction are freqently observed in Alzheimer's disease (AD), suggesting that hearing loss is
associated with cognitive decline in AD. Notably, impaired capacity to understand speech or detect sound
location is closely related to central auditory processing disorders, which appear several years before the
clinical diagnosis of AD. Thus, understanding how reduced auditory input impacts the auditory nervous system
is essential for developing therapeutic strategies for neural dysfunction in AD. However, the pathophysiologic
role of the auditory deficits in AD and their value for early detection of AD remain to be fully elucidated. Altered
myelination is a common pathophysiologic mechanism for neural circuit disruption, and causes deficits in
central auditory processing and cognitive decline. Our recent studies in normal adult mice suggest that sound
deprivation and enrichment dynamically change myelination, referred as adaptive myelination, which
contributes to auditory brainstem plasticity. However, the extent to which auditory experience-regulated
myelin plasticity contributes to central auditory processing in AD, and how adaptive myelination impacts AD-
related neuropathologic changes in the auditory nervous system, are unclear. In this proposed Administrative
Supplement to a parent NIH R01, the goal is to address how hearing loss impacts adaptive myelination, AD-
related neuropathologic changes in the auditory brain, and central auditory processing at the pre-symptomatic
stage of AD. We hypothesize that hearing loss decreases sound-evoked activity, impairs adaptive
myelination, and exacerbates neuropathologic features, leading to auditory processing deficits in AD mice at
the pre-symptomatic stage. Utilizing an Ab-aggregative AD mouse model, the APP/PS1 transgenic mouse,
we will 1) evaluate how auditory experience alters central auditory functions in AD mice, 2) examine how
sound deprivation alters oligodendrogenesis, oligodendrocyte maturation, and myelination, and 3) test
whether myelin loss impacts AD-related neuropathologic changes in the auditory nervous system. The study
will elucidate potential mechanisms underlying the link between hearing loss and AD, and how hearing loss
impairs auditory processing and cognitive functions in AD. These mechanistic studies could significantly
increase understanding of damaged auditory processing caused by myelin alterations, and contribute to
improving treatments for the decline in auditory perception and cognitive function in AD.

Public health relevance
Project Narrative The long-term goal is to identify neurophysiological mechanisms underlying central auditory dysfunctions to improve preventive/therapeutic strategies for auditory disorders caused by neurodegenerative such as Alzheimer’s disease (AD). Sound deprivation resulting from peripheral hearing deficits negatively impacts the central myelination and auditory circuit functions. The proposed study will reveal how hearing loss contributes to adaptive myelination and neural plasticity in the auditory brain circuitry in the AD model.